Impacts of Neighborhood Contexts and Medicaid Policy on Lung Cancer Survival in Low-SES Patients

PROJECT SUMMARY/ABSTRACT
Our prior work showed that Medicaid expansion under the ACA is associated with early detection and improved
survival in patients with non-small cell lung cancer, the most common type of lung cancer. However, Medicaid
enrollees with lung cancer still have much worse survival compared with their privately insured counterparts,
which is driven predominantly by their higher risks of being diagnosed at more advanced stages and under-
utilizing stage-appropriate cancer treatment. This suggests that equal healthcare coverage is essential, but
insufficient, to ensure equal access to lung cancer care and outcomes. Healthcare access has been
conceptualized as a result of the interactions between factors across the individual, provider and healthcare
system, neighborhood, and policy levels. However, prior studies addressing lung cancer disparities in low-
income patients focused on individual-level factors. We and other groups demonstrated that neighborhood
accessibility to cancer care is associated with treatment in patients with breast or colorectal cancer. Medicaid
enrollment pre- vs. peri-cancer diagnosis is associated with early-stage cancer diagnoses. Much less is known
about the influences of neighborhood contexts, Medicaid enrollment continuation, and Medicaid coverage of lung
cancer screening on lung cancer care in Medicaid patients. Tobacco cessation treatment is an integral and
essential part of lung cancer treatment. No study has examined the utilization of tobacco treatment and its
determinants in low-income lung cancer patients, a medically underserved population with high prevalence of
nicotine dependence. We hypothesize that neighborhood contexts, Medicaid policies, and hospitals play critical
roles in lung cancer care and survival in Medicaid patients. Employing a robust multilevel modelling approach to
account for clustering within providers and neighborhoods, we will assess the impacts of neighborhoods, policies,
and hospitals on early detection and oncologic treatment for lung cancer, utilization of tobacco treatment, and
lung cancer survival in Medicaid patients, as well as their contributions to racial disparities in lung cancer
treatment and survival. To this end, we will develop integrated datasets for Medicaid enrollees diagnosed with
lung cancer, which includes nationally representative cancer data, Missouri Medicaid claims and enrollment (also
Medicare claims for dual eligible enrollees), Missouri Cancer Registry data, Annual Hospital Surveys,
neighborhood contextual measures that we will develop. To our knowledge, this will be the first population-based
study to comprehensively assess the contributions of factors at the neighborhood, health policy, and hospital
levels to the lung cancer care continuum in low-income patients. The results will help inform interventions by
suggesting potentially modifiable factors that could be targeted to improve cancer care in this vulnerable
population and thereby reduce lung cancer disparities. Addressing non-financial barriers to cancer care in
Medicaid enrollees could maximize the likelihood that substantial investments in Medicaid expansion will
translate into true gains in cancer care access and outcomes for low-income patients.

Public health relevance
PROJECT NARRATIVE Although the disparity of lung cancer survival in low-income people is well documented, the determinants of lung cancer care in this vulnerable population remain undetermined. In the population-based cohorts of lung cancer patients insured with Medicaid, we will assess the impacts of neighborhood contexts, Medicaid policies, and hospitals on cancer-directed treatment, tobacco cessation treatment, and cancer outcomes, as well as their contributions to racial disparities in lung cancer treatment and survival. The results will enhance our understanding of the mechanisms for socioeconomic and racial disparities in lung cancer care and survival, and will also help identify modifiable targets for future multilevel lung cancer disparity interventions.